Metabolic Control of Membrane Lysis

Project Summary
Regulated cell death is essential for immune defense, development, and maintaining tissue
homeostasis. While apoptosis removes damaged cells without causing inflammation, lytic cell death pathways
such as pyroptosis and necroptosis may lead to excessive inflammation, contributing to chronic diseases and
autoimmunity. Recent discoveries suggest that metabolism not only fuels cellular functions but also actively
regulates the decision between survival and cell death. This project aims to explore how metabolic pathways
control the transition between life and death, particularly focusing on comparing the lytic cell death program
pyroptosis to the non-lytic cell death program apoptosis.
Our research will investigate key metabolic regulators that influence cell death executioners that control
membrane lysis including gasdermin D (GSDMD) and NINJ1. We will employ cutting-edge genetic and
synthetic biology approaches, including forward and reverse genetics with CRISPR/Cas9, metabolic profiling,
and engineered cell models, to uncover how metabolic signals determine whether cells commit to viability,
pyroptosis, or apoptosis. Our work will also explore how metabolites released during cell death communicate
with neighboring immune cells, shaping inflammatory responses and immune activation in vaccination, local
infection, and systemic sepsis.
By mapping the metabolic checkpoints that dictate cell fate, we aim to identify new therapeutic targets
for modulating cell death and inflammation. These mechanisms will inform precision treatments to prevent
excessive inflammation in autoimmune diseases, enhance immune responses in infections, and overcome
chemotherapy resistance in cancer. The integration of synthetic biology, genetics, and chemical biology makes
this a highly innovative and interdisciplinary project with significant implications for foundational research and
human health. Upon completion, we expect to provide new strategies to control cell death and improve
therapies for conditions where dysregulated cell death plays a pivotal role.

Public health relevance
Project Narrative Our research explores how metabolism controls whether immune cells survive or die after detecting pathogens and damage. Cancer cells and infections hijack these processes, altering metabolism and cell death to evade immune responses. By studying how metabolism influences cell death and how membrane rupture mediates communication through metabolite release, we aim to discover new ways to enhance cell death in cancer treatment and prevent harmful inflammation in diseases such as infections, autoimmunity, and aging.